The role of LDL in hemostasis

Hemophilia A is a hereditary bleeding disorder resulting from the absence or deficiency of coagulation factor
VIII (FVIII). More than 300,000 people worldwide are afflicted with hemophilia A. The severity of hemophilia A
is related to the residual FVIII activity (severe less than 1%, moderate 1-5%, and mild between 5-40% FVIII
activity); half of the patients have severe hemophilia. However, bleeding severity varies even within the same
category of hemophilia. The mechanism is unknown. Compared to an age-matched general population,
hemophilia patients have lower overall cardiovascular risk and lower levels of atherogenic low-density
lipoprotein (LDL)-cholesterol; the lowest LDL cholesterol levels being observed in those with the most severe
bleeding. Also associated with high LDL is impaired fibrinolysis, the primary mechanism to dissolve blood clots.
Fibrinolysis is initiated by the serine protease tissue-type plasminogen activator (tPA). A subgroup of patients
with severe hemophilia demonstrates a higher tPA concentration and increased fibrinolysis, associated with
severe bleeding. Recently we have made several observations that link LDL to hemostasis and thrombosis.
We have showed that: 1) LDL promotes thrombosis by enhancing von Willebrand factor (VWF) self-association
and subsequent platelet adhesion; 2) tPA binds apolipoprotein B (apoB), the core protein of LDL. The N-
terminus of apoB binds tPA’s Kringle 2 domain partially through its lysine-binding site, an interaction that may
interfere with tPA’s ability to initiate fibrinolysis. Therefore, we hypothesize that the low LDL in hemophilia may
lead to reduced VWF self-association and increased fibrinolysis. Our new preliminary data showed that 1)
hemophilia A patients have lower LDL-cholesterol and apoB with the lowest level in the severe group; 2) LDL
particles isolated from healthy volunteers or from wild-type mice accelerate clotting time in the whole blood of
hemophilia A mice; 3) LDL is associated with circulating FVIII and VWF; 4) lower apoB levels correlate with
faster clot lysis by recombinant tPA in hemophilia patients; and 5) a lysine analog partially blocks the
interaction between tPA and apoB. Based on these compelling data, the overarching objective of this proposal
is to test the central hypothesis that LDL improves hemostasis by increasing platelet adhesion, accelerating
clotting time, increasing clot strength, and inhibiting fibrinolysis. We propose three specific aims to test our
hypothesis. Aim 1. To test the hypothesis that LDL associates with FVIII-VWF and improves hemostasis. Aim
2. To test the hypothesis that LDL extends FVIII half-life with a slower clearance rate. Aim 3. To test the
hypothesis that LDL stabilizes clots by inhibiting fibrinolysis. In summary, by completing the proposed study,
we expect to elucidate the important role of LDL in hemostasis and characterize LDL as an antifibrinolytic
factor. It has not escaped our notice that the same mechanism by which LDL improves hemostasis in
hemophilia may also be pro-thrombotic when there are no hemostatic defects. This study's results have broad
implications for understanding the potential pro-thrombotic effects of LDL in cardiovascular diseases.

Public health relevance
Compared to an age-matched general population, hemophilia patients have lower overall cardiovascular risk and lower levels of atherogenic LDL cholesterol; the lowest LDL cholesterol levels being observed in those with the most severe bleeding. We propose to test the hypothesis that LDL improves hemostasis by increasing VWF self-association, platelet adhesion, accelerating clotting time, increasing clot strength, and inhibiting fibrinolysis. Completing the proposed study will elucidate the important role of LDL in hemostasis and characterize LDL as an antifibrinolytic factor.